Understanding the persistence of Dengue epidemic and associated risk factors in Urban Bamako Mali

Summary
Dengue fever disease (DFD) is an growing public health threat in Mali and in the West African Region,
particularly in urban Bamako, which has recently experienced significant epidemics with a case fatality rate of
2.8%. Despite the historic presence and recent outbreaks in the region there is limited knowledge on the
dynamic of DENV transmission and the severity of the disease because of limited diagnoses capacity and
misdiagnoses with other febril illnesses. The overall aim of this study is to assess burden and risk factor
associated with DFD its severity by conducting hospital-and community health facility-based fever surveillance
to characterize clinical profile of DFD in relation with DENV genomic profile, and population based serological
surveys to determine the seroconversion rate of exposure to DENV. We hypothesis is that genetic variations
in dengue virus strains, coupled with host immune response are associated with the incidence and severity of
DFD. Aim 1 will determine hospital and community health facility-based prevalence of DFD among febrile
patients and risk factors for severe dengue in Urban Bamako and rural setting in Mali. Aim 2: will determine
the prevalence and annual incidence of seroconversion to DENV infection in the general population around
study sites; and Aim 3: Investigate the genomic diversity and evolutionary dynamics of DENV in relation with
illness. By integrating hospital and community health facility-based fever surveillance, we will characterize the
clinical profile of DFD and identify risk factors for severe disease. Population-based serological surveys will be
conducted to determine the seroconversion rates and identify factors associated with asymptomatic DENV
infections. Utilizing advanced genomic techniques such as virome capture sequencing (VirCapSeq-VERT), we
will investigate genetic variations in DENV strains and their correlation with disease severity and transmission
dynamics. We hypothesize that genetic variations in DENV strains, coupled with host immune responses,
influence the incidence and severity of DFD. The study will provide valuable information the burden and risk
factors associated with DFD that can contribute to refine the clinical guide for dengue classification and
treatement based on combination of clinical symptoms and laboratory testing. The outcomes will inform the
design of effective public health interventions and vaccine development.

Public health relevance
Narrative The proposed research addresses the significant public health challenge of dengue fever disease (DFD) in Mali, focusing on urban Bamako, which has experienced severe recent epidemics. This study aims to fill critical gaps in understanding the dynamics of DENV transmission, the genetic diversity of circulating strains, and the population’s immune response. Through hospital and community health facility-based fever surveillance, we will characterize the clinical profile of DFD and identify risk factors for severe disease. Population-based serological surveys will determine the seroconversion rate and identify factors associated with both asymptomatic and symptomatic DENV infections. Advanced genomic techniques such as virome capture sequencing (VirCapSeq-VERT) will be employed to investigate genetic variations in DENV strains and their correlation with disease severity and transmission dynamics. This multidisciplinary approach will enhance our understanding of DENV epidemiology in Mali, providing insights into factors driving the persistence and severity of DFD outbreaks.